EFFECTS OF OXYGEN SATURATED MINERAL WATER AND GATORADE ON BLOOD LACTATE RESPONSE

We hypothesize that administration of oxygen saturated mineral water or Gatorade will have no effect on the blood lactate response to exercise, maximal oxygen consumption, or endurance performance.